Education & Training

The Center will allocate $109,067 to the Education and Training Unit. From these funds, an allocation of $6,300 will be made to establish a unique semester-long course within the PS-OC, including a webcast for an external audience, entitled,

Public health relevance
The education and training programs of the PS-OC will ensure that the staff of the PS-OC is well trained, that the knowledge generated within the Center is available to other interested parties, and that evolutionary theory of cancer becomes accepted as a field of its own.